Physiology of Thyroid Hormone-Dependent Gene Expression

? DESCRIPTION (provided by applicant): Thyroid hormone has major effects on the development, regeneration and function of skeletal muscle. Thyroid hormone receptor α1 is the predominant mediator of muscle T3 action, and transcriptionally regulates a number of important genes including SERCA A1 and A2, UCP 3 and GLUT 4, as well as the muscle differentiation factors myogenin and MyoD1. Circulating T3 enters myocytes via specific transporters such as MCT8 and 10, but we have shown in the last cycle of this grant that a significant fraction of cellular T3 is generated by the intracellular monodeiodination of T4 catalyzed by the type 2 iodothyronine deiodinase (D2). While mature myocytes are stable, skeletal muscle has a robust regenerative mechanism that is markedly accelerated following injury. This involves the concerted actions of satellite cells, the muscle stem cell equivalent, an a number of different cell types localized to the muscle stem cell niche including resident stromal fibro/adipogenic progenitors (FAPs), T-regulatory cells, and macrophages. These cells produce a number of pro-myogenic cytokines and growth factors that that are necessary to coordinate the regeneration process including Notch, Wnt/β-catenin, sonic hedgehog, IL-4 and IL-6, and a number of TGF-β?family members among others. During the last grant period, we showed that changes in thyroid hormone mediated by local thyroid hormone metabolism play an important role in these signaling cascades. We found that after muscle injury acute inactivation of thyroid hormone by the type 3 iodothyronine deiodinase (D3) is necessary to facilitate satellite cell proliferation and block premature differentiation that otherwise would lead to apoptosis. This is followed by increased type 2 deiodinase (D2)-mediated T4 activation that is essential for the satellite cell to differentiate into mature myoblasts and then myofibers to complete the normal muscle regeneration program. In studies employing gene knockout mouse models, we have found that a loss of either D3 of D2 dramatically impedes muscle repair after injury. Using a murine model of satellite cell transplantation therapy, we further showed that local thyroid hormone activation by D2 plays a crucial role in the engraftment of transplanted muscle stem cells. In this renewal, we propose to combine studies using our unique mouse knockout models and established FACS-sorting isolation of specific cell types. We will investigate why D2 is required for engrafted satellite cell survival and successful myotube formation, how D3 and D2 change after injury in satellite cells and other components of the muscle stem cell niche, whether deiodinases are required for the coordinated responses of other cell types in the muscle stem cell niche, and how dysregulation of this process may lead to fibrosis. This will expand our knowledge of the contributions of thyroid hormone to muscle regeneration and form the basis for potential therapeutic strategies for patients with skeletal muscle injuries.

Public health relevance
PUBLIC HEALTH RELEVANCE: We have found that thyroid hormone (T3) levels in skeletal muscle are very tightly regulated by intra-tissue activation and inactivation, and if this is lost injured muscle is unable to fully repair itself. We will define how T3 controls muscle repair in multiple cell types using biochemical and molecular biologic techniques with the goal of discovering therapies to enhance muscle regeneration after injury in: the elderly, athletes, individuals with accidental and occupational injuries, and patients with chronic degenerative muscle disease.